Untangling the influence of distinct sources of somatosensory feedback on the neural dynamics of dexterous movement control

PROJECT SUMMARY
To move successfully, we must be able to sense our bodies and our environment. This is no more evident
than when participants attempt to strike a match to light a candle after their hand’s somatosensation has been
numbed. Despite being able to see well, participants fumble with the match and clumsily attempt to accomplish
the task. Further, somatosensory-motor integration is notably impaired in many types of neurological movement
disorders including Parkinson’s disease, stroke, essential tremor, and dystonia. Developing rehabilitation or
therapeutic strategies to improve somatosensory-motor integration faces a central challenge: while the
theoretical importance of somatosensory-motor integration (SMI) is clear, how the brain actually processes
afferent signals to enable excellent movement control remains unclear.
In this proposal, we seek to use a population neural dynamics framework to understand how the brain
implements SMI computations. Specifically, we will leverage a novel feedback-dependent dexterous
manipulation task, high-density multi-area recordings, and an innovative type of electrical stimulation that can
be used to modulate inter-area communication in the macaque monkey. These combined experiments and
analysis are designed to uncover how SMI computations, long known to be critical for movement control, are
implemented in population neural activity patterns in brain. Further, they will pave the way for developing
approaches for restoring damaged SMI in the brain after brain injury or neurodegenerative disease.
The main experimental approach of this proposal includes simultaneous high-density, high channel-count
(Neuropixel) electrophysiological recordings from the primary motor cortex (M1), primary somatosensory cortex
(S1), and cerebellar-receiving motor thalamus (mThal) in non-human primates that are learning and executing a
dexterous manipulation task. The main analytical approach includes modeling the timeseries of motor cortical
population activity as a combination of intrinsic motor cortical dynamics and inputs from S1 and mThal. The
hypothesis of this proposal is that S1 and mThal exert different influences on M1 population dynamics throughout
the learning and execution process. Specifically, we hypothesize that S1 provides specific sensory updates that
drive M1 population activity, and mThal modulates the temporal dynamics of M1 population activity. We will
further develop evidence for or against this hypothesis by leveraging a novel neuromodulation approach that can
boost or interrupt communication between distant brain regions. Completion of this proposal will constitute an
understanding of how SMI computations, that have long been thought to be essential for movement, are actually
implemented in the circuitry and population dynamics of the macaque sensorimotor system. This advance would
improve our understanding of how to target somatosensory nodes to improve control of movement following
motor impairment.

Public health relevance
PROJECT NARRATIVE To move successfully, we must be able to sense our bodies and our environment. While theoretical work outlines computations that ought to take place for successful integration of somatosensation into movement, how population neural activity in somatosensory and motor nodes in the brain interact to accomplish this integration remains unclear. This proposal uses multi-area electrophysiology to monitor functional interactions in distributed sensorimotor nodes during the acquisition and execution of a dexterous manipulation task, mapping theoretical computations onto the circuits and cross-area population dynamics in the sensorimotor network.